The Senior Connection

DESCRIPTION (provided by applicant): There is a pressing need for interventions that reduce risk for suicide in later life. Older adults in the U.S. have the highest rate of suicide and are the fastest growing segment of the population. We can anticipate a large rise in the number of older adults who die by suicide in coming decades. This application is in response to RFA-CE-10-006. Consistent with the CDC's key strategy of reducing suicide by promoting connectedness, our long-term goal is to reduce late life suicide-related morbidity and mortality by leveraging the resources and expertise of the aging services provider network (ASPN) to address unmet social needs of community-dwelling older adults. Our objectives with this proposal are (1) to examine whether linking socially disconnected seniors with peer supports through the Retired and Senior Volunteer Program (RSVP) is effective in reducing risk for suicide, and (2) to test an hypothesized mechanism for the association of social disconnectedness and suicidal ideation and behavior informed by the Interpersonal Theory of Suicide. We will recruit 400 primary care patients (200 men and 200 women) over age 60 years who endorse feeling lonely and/or as if they are a burden on others. They will be randomly assigned to either of two conditions. Those assigned to The Senior Connection (TSC) will either be paired with a peer companion or, if they prefer and are eligible, be trained and placed as a peer companion for others by RSVP. The comparison group will receive no further intervention (care-as-usual [CAU]). Subjects will be followed for up to 24 months with repeated in-home (baseline, 12, and 24 months) and telephone assessments (3, 6, and 18 months). The study has four specific aims: (1) To compare the impact of TSC and CAU on social connectedness of older adult primary care patients; (2) to compare the effectiveness of TSC and CAU in reducing factors associated with proximal risk for suicidal behavior; (3) to determine if changes in measures of older adults' social connectedness mediate the relationship between social connectedness and suicide risk; and (4) is to examine whether responsiveness to the intervention differs by gender.

Public health relevance
PUBLIC HEALTH RELEVANCE: The Retired and Senior Volunteer Program (RSVP) is offered in communities nationwide by social service agencies that are dedicated to maintaining the independence and quality of life of older adults. Their expertise and resources are well suited to the reduction of suicide risk in later life. If RSVP is shown to be effective in reducing suicidal ideation and increasing connectedness, it will be easily disseminated across the aging services provider network as a means to prevent suicide among seniors at risk. The Retired and Senior Volunteer Program (RSVP) is offered in communities nationwide by social service agencies that are dedicated to maintaining the independence and quality of life of older adults. Their expertise and resources are well suited to the reduction of suicide risk in later life. If RSVP is shown to be effective in reducing suicidal ideation and increasing connectedness, it will be easily disseminated across the aging services provider network as a means to prevent suicide among seniors at risk. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS There is a pressing public health need to find interventions that reduce risk for suicide in later life. Older adults in the U.S. have a higher rate of suicide than younger adults or adolescents 1,2. They are the fastest growing segment of the population as well 3,4. The leading edge of post-World War II "baby boomers", 78 million Americans born between the years 1946 and 1964, reaches 65 years of age in 2011 5. We can anticipate a very large rise, therefore, in the number of older adults who die by suicide in coming decades 6. Psychiatric and physical illness, functional decline, and social factors place seniors at risk for suicide 7,8,9,10. Social factors include stressful life events,10 family discord,11 and insufficient social supports 8,12,13. Reflecting this body of evidence, the CDC has identified as its key strategy for preventing suicidal behavior at all ages the promotion and strengthening of connectedness at personal, family, and community levels. We believe this approach is especially well suited to older adults. The goal of our program of research is to reduce late life suicide-related morbidity and mortality by leveraging the resources and expertise of the aging services provider network (ASPN) to address unmet social needs of community-dwelling older adults. Our premise, based on work supported by an NIMH-funded Interventions and Practice Research Infrastructure Program grant (R24 MH071604; Y. Conwell, PI), is that community-based social service agencies represent an untapped resource for the detection and management of social factors, such as disconnectedness, that place seniors at risk for suicide. Lifespan, the Monroe County area's largest aging services provider, and University of Rochester researchers are collaborating partners for the R24 grant and this proposal. We have two primary research objectives. The first is to examine whether linking socially disconnected seniors with peer supports through the Retired and Senior Volunteer Program (RSVP)(either as the recipient or provider of volunteer companion services) is effective in reducing risk for suicide (defined both as reduction in suicidal ideation as well as change in more "distal" factors associated with risk for suicide in seniors). We refer to the intervention as "The Senior Connection" (TSC). Second, we will test a model to explain the "mechanism" for the association of social disconnectedness and suicidal ideation and behavior - the Interpersonal Theory of Suicide14,15. Insights into the means by which disconnectedness may lead to suicide will enable development of more refined and effective interventions in future research. We will recruit 400 primary care patients (200 men and 200 women) over age 60 years who endorse feeling lonely and/or as if they are a burden on others. They will be randomly assigned to either of two conditions. Those assigned to TSC will either be paired with a peer companion or, if they prefer and are eligible, be trained and placed as a peer companion for others by RSVP, a component of Lifespan. Other subjects will receive no further intervention (the "care-as-usual" [CAU] or control condition.) Subjects will be followed for up to 24 months with repeated in-home (at baseline, 12 and 24 months) and telephone assessments (at 3, 6, and 18 months). Specific aims of the study and associated hypotheses are: Aim 1: To compare the impact of TSC and CAU on social connectedness of older adult primary care patients. We measure two types of social connectedness: (i) structural and (ii) psychological. We hypothesize that at the structural level, TSC will be more effective than CAU in increasing (a) instrumental social support and (b) social network size, density, and quality. At the psychological level, TSC will be more effective than CAU in decreasing older persons' feelings of (a) thwarted belongingness and (b) perceived burdensomeness. Aim 2: To compare the effectiveness of TSC and CAU in reducing factors associated with proximal risk for suicidal ideation and behavior in older primary care patients. We hypothesize that compared with CAU, subjects who receive TSC will have (a) less death ideation, hopelessness, and depressive symptoms; and (b) greater reasons for living, perceived personal and social worth, and perceived meaning in life. Aim 3: To determine if changes in older adults' perceptions of thwarted belongingness and perceived burdensomeness mediate the relationship between social connectedness and suicide risk. Consistent with the Interpersonal Theory, we hypothesize that social connectedness results in reduced thwarted belongingness and perceived burdensomeness, which in turn lead to reductions in more proximal risk factors for suicide. Aim 4: To examine whether responsiveness to the intervention differs by gender. We expect no differences for men and women. While a non-significant finding for gender does not allow us to conclude that the null hypothesis is "true," given our study's statistical power to detect even a clinically-meaningful effect, we could conclude that the magnitude of differential effectiveness is small enough to lack clinical significance. This finding will have important implications for prevention, given the high rates of suicide among elderly men. In secondary analyses we will examine in those who received TSC whether characteristics of the intervention (whether one gives and/or receives peer support; number and type of peer support contacts; quality of the relationship) are associated with response in the study's primary outcomes. The findings from the study will guide the implementation and dissemination of RSVP-sponsored peer social support interventions through Area Agencies on Aging, which administer RSVPs, across the United States.